Integrating Cutting-Edge Whole Person HIV and Substance Use Care in Vietnam and Beyond

PROJECT SUMMARY
Young men vulnerable to HIV due to sexual behaviors are experiencing an ongoing HIV epidemic in Vietnam,
with an HIV prevalence of 12%. However, HIV testing and pre-exposure prophylaxis (PrEP) use among this
population remain low. To improve HIV testing and PrEP use, mobile health (mHealth) interventions hold great
promise to reach young men in low- and middle-income countries. HealthMindr, an evidence-based mHealth
intervention developed in the United States for men at high risk for HIV, is an ideal option for adaptation for
young men in Vietnam. I propose to adapt this app and explore barriers and facilitators of implementing the
app among this population. The specific aims are to (1) Adapt the HealthMindr app to improve HIV testing and
PrEP uptake among young men at high risk for HIV in Vietnam; (2) Examine acceptability, feasibility and
preliminary effectiveness of the adapted app among young men at high risk for HIV in Vietnam and (3) Explore
barriers and facilitators of implementing the adapted app among young men at high risk for HIV in Vietnam. In
Aim 1, theater testing will be conducted through focus group discussions with young men and key other
stakeholders, including health officials, clinic staff and community-based organizations. Theater testing data
will be used to refine the app for beta testing. During beta testing, a small group of young men at high risk for
HIV will use the app for 30 days, then complete an online survey and an exit
usability, provide their perspectives of the app and report any other areas for improvement. App analytics will
also be collected to understand whether and how the app is used. In Aim 2, the adapted app with be tested
among young men at high risk for HIV through a randomized controlled design. Young men will be randomized
into the intervention or control arm (1:1 ratio). The intervention arm will have full access to the app for 3
months, while the control group will receive standard-of-care HIV services. Key app features include HIV test
planning, risk and PrEP eligibility assessment, ordering of free condoms and HIV test kits, information about
PrEP, and PrEP provider and HIV testing locations. HIV testing and PrEP use will be assessed at baseline and
3 months and compared between groups. A mixed methods approach will be used to evaluate app
acceptability and feasibility. Quantitative data on acceptability and feasibility will be collected through the 3-
month online survey, while qualitative data will be collected through in-depth interviews with a subset of young
men in the intervention arm and other key stakeholders. In Aim 3, through the same qualitative study as Aim 2,
factors that influence the implementation of the app will be explored. Determinants from seven domains will be
identified: condition, technology, value proposition, adopter system, health organization, wider system and
embedding/adaption over time. This proposal will generate data for designing a full-scale hybrid type 1
effectiveness-implementation trial to test the adapted app and identify implementation strategies to address the
barriers of app implementation in low- and middle-income countries.

Public health relevance
PROJECT NARRATIVE Even though young men at high risk for HIV in Vietnam are disproportionately affected by the HIV epidemic, HIV testing and pre-exposure prophylaxis (PrEP) uptake among this group are low. By proposing to adapt an mobile health intervention developed in the United States for young men at high risk for HIV in Vietnam and explore barriers to implementing the app, the proposed study will provide critical guidance for the implementation of mHealth interventions for HIV prevention, not only in Vietnam but also in other low-resource settings. This research holds great potential to improve HIV testing and PrEP use among young men at high risk for HIV and significantly contribute to the goal of ending the AIDS epidemic globally.